Leadership and Administration Core

The Seattle TREC Center organization and administration is designed to optimize the leadership and support to the scientific endeavors of its investigators, five projects, and five cores, and to support the inter- TREC Center collaborations. The Seattle TREC Center will be led by Anne McTiernan, MD, PhD, a Member" in the FHCRC Public Health Sciences (PHS) Division and Director of the FHCRC Prevention Center. Dr. McTiernan is an international leader in the area of energy balance and cancer, and will provide scientific direction to the Seattle TREC Center in components of energy balance and cancer prevention research. She has conducted seminal work in human exercise intervention studies and cancer biomarkers. Dr. John Potter, MD, PhD, FHCRC Senior Vice President and Director of the PHS Division will co-lead the Center. Dr. Potter, an internationally reknowned leader in nutritional and molecular epidemiology and cancer prevention, has particular strength in working across disciplinary boundaries and integrating data from a variety of models in order to pose specific etiology/prevention questions, and has led several large transdisciplinary research programs including a Program Project Grant focused on the etiology of several gastrointestinal cancer. The major decision-making body of the Seattle TREC Center will be an Executive Committee, which will be comprised of all project and core leaders. The Executive Committee, chaired by Dr. McTiernan, will meet monthly, and will provide scientific oversight and guidance to individual projects including review and approval of protocols, and monitoring progess of individual projects and cores. We will employ several means of fostering transdisciplinary collaborations across the Seattle TREC Center, including the regular Executive Committee meetings, quarterly meetings of the Scientific Program Committee (consisting of all TREC investigators), a seminar series with talks by TREC and other researchers in related areas. Institutional commitments include salary support to key investigators, subsidized laboratories resulting in lower study assay costs, and the unique FHCRC Prevention Center that will provide support to the human .interventions. The Seattle TREC investigators are very experienced with national collaborative studies, and will be eager participants in collaborative interdisciplinary work across the TREC Community.